Admin Core

Program Director/Principal Investigator (Last, First, Middle): STERGIOU, NICK
Project Summary
DESCRIPTION (provided by applicant): The overall goal of the Administrative Core (ADMIN) is to coordinate the
development, high-impact functioning, and sustainability of the Center for Research in Human Movement
Variability (MOVCENTR) at the University of Nebraska at Omaha. This core is crucial in facilitating meaningful
interactions and insightful input from key stakeholders, such as investigators, leadership, core directors, technical
staff, and consultants. Additionally, it supports the scientific cores and COBRE research plans that address
center, university, and national/international priorities in our field. We administer a highly interconnected program
that aligns with the needs of the user base and COBRE initiatives to take optimal advantage of the university's
resources for the COBRE to exert a sustained, powerful influence on restoring healthy human movement
variability across a range of movement disorders. The Executive Committee (EC), which includes the PD/PI
(Stergiou) as Chair, the Core Directors, the Financial Administrator, and the Program Coordinator, as well as the
Advisory Committee (AC), provides input and support to PD/PI to oversee the ADMIN and manage all necessary
operations. The EC and AC are comprised of individuals with a wide range of experience and skills in research
and administration. The ADMIN combines a comprehensive assessment strategy, sound operations and
budgetary management, cooperation with NIGMS program staff, a highly successful pilot project program, and
strong visionary leadership to ensure financial sustainability and programming effectiveness.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page